BCCMA: Recovery of Aged Muscle After Disuse Atrophy (REMEDY): Integrating multimorbidity, multi-omics, physiology, and biomarkers to define hospital acquired muscle atrophy and recovery (ANTICIPATE)

Shared paragraph: The aging Veteran population has more frequent inpatient hospitalizations than non-Veteran
populations. In older Veterans there is an inability to fully recover muscle mass and function after hospital-
acquired weakness. The consequence of repeated periods of disuse is a hastening of the progression to disability
or frailty for older Veterans. We hypothesize that anticipatory and/or early interventions are critical to maintain
muscle mass and function in older Veterans. To address this hypothesis, our specific aims are to: 1) use pre-
clinical models to understand biological mechanisms of failed regrowth and potential therapeutic approaches, 2)
leverage precision medicine and phenotyping to predict the onset and identify risks and underlying etiology of
hospital-acquired weakness in high risk Veterans with multiple morbidities, and 3) determine clinically viable
methods of characterizing and monitoring disuse muscle atrophy and its impact on physical functioning and
resilience.
Muscle atrophy during hospitalization hastens disability leading to accelerated functional decline, decreased
quality of life, and increased risk of mortality. Project 3 of REMEDY, entitled Integrating Multimorbidity, Multi-
omics, Physiology, and Biomarkers to Define Hospital Acquired Muscle Atrophy and Recovery (ANTICIPATE)
will leverage precision medicine and phenotyping to predict the onset and identify risks and underlying etiology
of hospital-acquired weakness in older Veterans with significant multimorbidity and high risk of hospital
admission. We hypothesize multi-omic, physiological, and molecular measures will augment existing health
status and admission risk calculators enabling the future application of targeted interventions to prevent muscle
atrophy, maintain strength, and improve recovery in high-risk Veterans. This prospective cohort will use national
VA electronic health records (EHR) and clinical assessments before, during, and after hospitalization in Veterans
at three diverse VA Healthcare Systems (Salt Lake City, Los Angeles, and Birmingham). The study will utilize a
composite clinical and polygenic risk score developed using data from VA EHR, the Million Veteran Program
(MVP), and VA-specific multimorbidity admission risk calculators to identify and characterize older Veterans who
are at increased risk of hospitalization (AIM 1), determine the impact of hospitalization on muscle health and
recovery in high-risk Veterans with multimorbidity (AIM 2), and identify novel biomarkers that predict
hospitalization, disuse muscle atrophy, and recovery (AIM 3). Overall, as part of the collaborative REMEDY trial,
ANTICIPATE will provide a novel and comprehensive screening of high risk Veterans that will be most impacted
by the hospitalization. Our unique approach will detail the physiological and molecular measures before, during
and after hospitalization that, when combined with the other REMEDY projects, will allow for the rigorous testing
of anti-aging and muscle-centric approaches to improve recovery after hospitalization in older Veterans.

Public health relevance
The prevalence of multimorbidities, defined as the presence of two or more chronic health conditions, is strikingly high in older Veterans. Importantly, Veterans with multimorbidities have the highest rates of hospitalization and are at the greatest risk of hospital acquired weakness and disability. We will deeply characterize older Veterans with multimorbidity before, during, and after inpatient hospitalization and use these data to advance therapeutic interventions, augment admission risk calculators, and improve recovery. The specific aims will focus on advancing a composite risk score to identify Veterans who are at greatest risk for hospitalization (AIM 1), determining the impact of hospitalization on skeletal muscle health and recovery (AIM 2), and identifying predictive biomarkers associated with increased risk of hospitalization, hospital acquired muscle atrophy, and recovery. As part of the REMEDY trial, this project provides a critical step towards identifying Veterans that are most at risk for hospitalization and likely to benefit from interventions aimed at improving recovery.